Disrupting Implicit Bias in Dental Clinical Decision-Making and Mitigating Its Effect on the Dentist-Scientist Workforce Pathway

PROJECT SUMMARY
Bias is a significant contributor to health disparities and health inequities; and rises to the level of a public
health problem. Research has consistently shown that implicit bias effects the healthcare system, resulting in
differential outcomes: medical treatment care quality; patient-provider communication; and trust in the medical
system. Significant research has explored the impact that implicit bias has in medical settings, with studies
focused on physicians and nurses. There is, however, a gap in the evidence-base regarding oral health and
dentists.
Understanding the role that implicit bias plays in clinical dentistry—both in clinician decision-making
and in the recruitment/ retention of the oral health workforce—is essential to advancing health equity and
closing the gap in health disparities. This project’s objectives are to (1) assess the multi-level impact of implicit
bias on oral healthcare: clinician decision-making and the recruitment/retention of a diverse, oral health
research workforce; (2) to mitigate the impact of implicit bias and advance oral health equity through the
implementation of implicit bias interventions for dentists and psychosocial support for underrepresented
trainees. This project is a combination of research approaches and Diversity, Equity, Inclusion and
Accessibility (DEIA) activities. The specific aims are to 1) determine the prevalence and impact of treatment
planning bias in a national sample of dentists; 2) identify and describe critical facilitators and barriers to
effective implicit bias training among dentists; and 3) demonstrate the effects of psychosocial barriers,
including implicit bias, on the recruitment of underrepresented groups to the dentist and oral health research
workforce. In this mixed methods approach of observational and interventional research design, rigor and
reproducibility comes from randomization of dentists to clinical vignettes of Black and white patients and time-
sequenced analysis of the impact of implicit bias training. Focus groups with underrepresented undergraduate
students participating in research pathway programs at dental schools will provide data to identify critical
facilitators and barriers to the recruitment and retention of an oral health workforce that is representative of the
U.S. population.

Public health relevance
PROJECT NARRATIVE Understanding the role that implicit bias plays in clinical dentistry—both in clinician decision-making and in the recruitment/ retention of the oral health workforce—is essential to advancing health equity and closing the gap in health disparities. The current project focuses on clinician decision-making by establishing a baseline prevalence of implicit bias among dentists in the United States and supporting dentists with implicit bias training. To advance diversity in the workforce, this project will provide psychosocial support to help students actively pursuing careers in the biomedical research enterprise mitigate the effects of implicit bias and other barriers to successful entry into the oral health workforce.